Cytoskeleton, Nucleus and Integrin Recycling in Cell Migration

SUMMARY
This application for an Administrative Supplement requests an epifluorescence, FRET and TIRF microscope to pursue the
goals of the parent R35 grant to understand two aspects of cell migration for which we have limited understanding: nuclear
positioning and integrin recycling. Both these processes are essential for cell migration, yet how they contribute at a
mechanistic level to cell migration is lacking. The parent R35 grant seeks to build on results previously obtained in two
previous projects in the Gundersen laboratory supported by NIGMS. For nuclear positioning, we will examine how the
linker of nucleoskeleton and cytoskeleton (LINC) complex is mechanically reinforced to resist the large forces necessary
to move the nucleus and will use and develop new FRET tension sensors to directly measure forces on the nucleus. We
will determine how the LINC complex selects actin filament or microtubules for nuclear movement and the functional
consequences of these interactions for different modes of cell migration. We will test new hypotheses that the nucleus
functions as a “tension resistor” for actin filaments and as a polarity factor for microtubule trafficking. For integrin
recycling, we will test the overall hypothesis that recycled integrins travel in an active conformation and that this seeds
new adhesion formation in a polarized manner near the leading edge. We will use new integrin probes and a new integrin
recycling system coupled with TIRF microscopy to identify the intracellular pathway of recycling integrins, their sites of
integrin exocytosis relative to newly formed adhesions. We will also use TIRF microscopy to determine whether recycled
integrin derives from the cell rear during migration and contributes to nascent adhesion formation near the leading edge.
We will identify the microtubule machinery that we hypothesize is responsible for the polarized reformation of adhesions
from recycled integrins and test the possibility that the recycled integrin plays a role in integrin signaling. We will explore
whether these two aspects of cell migration can be linked by determining with FRET imaging of tension sensors whether
the nucleus mechanically engages substrate adhesions. Our proposed studies on these two processes will advance
understanding of the basic mechanisms of cell migration and potential identify new targets for intervening in cases when
cell migration goes awry. The proposed studies will also provide fertile ground for postdoctoral fellows and graduate
students to advance their training and develop their own projects.

Public health relevance
PROJECT NARRATIVE Cell migration is a fundamental property of most cells and contributes to development, wound healing, immune responses and a host of other processes. This project focuses on two poorly understood processes in cell migration: nuclear positioning and endocytic recycling of integrin adhesion receptors. Deciphering the contribution of these processes to cell migration will provide new basic information to understand cell migration and may help identify new strategies for intervention in cases where cell migration becomes unregulated, such as cancer metastasis and inflammation.